Resource Support Core (RSC)

RESEARCH SERVICES CORE SUMMARY
Research Services Core (RSC) capitalizes on expertise from several departments at UMMC and on well-
established animal models of preeclampsia (PE) that were developed and characterized by UMMC investigators.
There is strong synergy between projects since all projects utilize the same animal models and projects are
examining common pathophysiological pathways and phenotypic endpoints. This Core will provide project
investigators with access to state-of-the-art equipment and the expertise needed to explore various aspects of
the role of inflammation in the development of hypertension and neurovascular dysfunction in PE. RSC will
provide centralized facilities, equipment, personnel, and services that will be extensively used and are vital to
the success of all the projects in this program. Jan Williams, PhD will serve as the Core Director assisted by
Richard Roman, PhD, as Associate Core Director. The RSC is divided into 3 subcores: 1)Animal; 2) Vascular
Function; 3)ImmunoBiology. The Animal SubCore will supply centralized services and personnel for rigorous
and reproducible surgical procedures to generate the clinically relevant and well-established models of PE
including the Reduced Uterine Perfusion Pressure (RUPP) rat model of placental ischemia using Sprague
Dawley (SD) rats, and Nude Athymic (rnu/rnu) rats, measure renal function and blood pressure, characterize
male and female differences in cardiovascular function of offspring, and assess cognitive decline in pregnant
postpartum models of PE and in the offspring in order to better understand sex differences observed in offspring
of women with PE. The Vascular SubCore will provide state-of-the-art equipment and the expertise needed to
explore various aspects of systemic and organ-specific hemodynamic parameters, assess endothelial function
and vascular reactivity, in vivo vascular imaging, in vivo and ex vivo neurovascular characterization, in vitro
molecular and cellular imaging and respiration analysis, proteomics, and reactive oxygen/nitrogen species
quantification. The Immunobiology SubCore will establish standardized immunology-based protocols for,
measuring immune cell and cytokine levels in plasma and various tissues, measure angiotensin receptor
autoantibody levels using a cardiomyocyte contraction assay, and provide histological slide preparation, staining,
visualization and quantification. Core personnel will provide expert assistance in developing new assays and
training of SCORE personnel including graduate students, post-doctoral fellows, research technicians ESIs and
pilot project PIs in standardized protocols, data analysis and interpretation of results, and use of Core equipment
and analytical tools for all projects.

Public health relevance
RESEARCH SERVICES CORE OVERVIEW-NARRATIVE The Research Services Core (RSC) capitalizes on expertise from several departments at UMMC and on animal models of preeclampsia that were developed and characterized by UMMC investigators. The RSC will serve as a dynamic resource to facilitate the aims of this SCORE to address the pathogenesis of placental– induced cardiovascular and neurovascular dysfunction in the mother and in male and female offspring and identify therapeutic options to improve maternal and offspring morbidity and mortality.